Allosteric mechanisms driving paradoxical activation of RAF kinases

ABSTRACT
Mutations in the BRAF protein kinase are key drivers of melanoma, thyroid cancer, and colon cancer. Existing
drugs, like vemurafenib, that target the most common BRAF mutant (V600E) are initially effective in patients, but
clinical resistance invariably develops after a few months. V600E BRAF normally signals as a monomeric kinase,
which is readily inhibited by these first-generation drugs. Resistance to these drugs is mediated by BRAF
dimerization, which triggers a conformational change of the kinase from an “C-out to an “C-in” state and blocks
drug binding. New inhibitors have been developed to recognize the C-in state and thereby target BRAF dimers,
but these molecules exhibit a mysterious phenomenon called paradoxical activation in which they can increase
BRAF activity under some conditions, rather than inhibit it. Paradoxical activation is linked to induction of BRAF
dimers by inhibitors, but the underlying molecular mechanism is not well understood, rendering it challenging to
design new inhibitors that avoid it.
Using an integrated biophysical approach, we built a model for paradoxical activation that describes the
allosteric coupling between inhibitor binding and BRAF dimerization in quantitative thermodynamic terms. In our
approach, a dataset of FRET measurements that quantify inhibitor-driven BRAF dimerization are globally fit to
our dimerization model, yielding thermodynamic parameters that describe the allosteric coupling mechanisms
underlying drug-driven BRAF dimerization. Remarkably, the results show that inhibitor-driven dimerization is
asymmetrical, with the first drug binding event triggering dimerization strongly, and the second binding event
contributing little additional dimerization affinity. This model accurately predicts the shape of BRAF kinase
activation curves measured as a function of inhibitor concentration, demonstrating that it provides a realistic
physical framework for understanding paradoxical activation.
We plan to use this approach to expand our understanding of paradoxical activation in RAF kinases. In Aim
1, we classify a large set of RAF inhibitors based on their allosteric coupling strengths and the conformation of
the C-helix they promote, unraveling the mechanistic connection between inhibitor binding, conformational
change, and BRAF dimerization. In Aim 2, we apply this approach to oncogenic mutations of BRAF to understand
how these mutations are coupled to inhibitor-driven dimerization and activation. In Aim 3, we extend our studies
to higher-order complexes of BRAF, including the scaffolding protein 14-3-3, which can either weaken or
enhance BRAF dimerization depending on the mode of interaction, and BRAF/CRAF heterodimers, which are
an important signaling species in cells with catalytically-inactive oncogenic BRAF mutations. Collectively this
work will reveal the molecular mechanisms underlying paradoxical activation of RAF complexes and aid the
design of new inhibitors that avoid triggering paradoxical activation.

Public health relevance
NARRATIVE Drugs developed to selectively block the oncogenic kinase BRAF often exhibit a mysterious phenomenon called paradoxical activation in which they fail to inhibit and instead increase BRAF activity. This project uses new biophysical approaches to dissect the molecular mechanisms underlying paradoxical activation with the goal of guiding the design of new drugs that more effectively block BRAF activity.